Genomic Translation Across Species Core

ABSTRACT- Genomic Translation Across Species Core
The overarching goal of the Genomic Translation Across Species Core (GTASC) aligns with the larger mission
of the Nathan Shock Center, to advance translational research on biological processes contributing to aging-
related outcomes through interdisciplinary collaboration. While there has been much progress in using model
systems to understand biological processes underlying aging phenotypes related to healthspan and disease, the
translation of findings in model organisms from biologists to clinicians in order to validate genetic, transcriptomic,
or epigenetic associations with age-specific indicators in humans occurs very slowly, as does bringing findings
back to model systems for experimental manipulation. The GTASC has a unique set of resources and expertise
with which to facilitate translational processes in normal aging samples, with diversity in sex/gender and
race/ethnic composition, and with age ranges from 50 to 109, thereby enabling the potential to accelerate the
rate of therapeutic discovery for many aging-related diseases. This core leverages expertise in the methods and
analysis of phenotypes derived from large-scale, nationally representative, normal aging cohorts, and makes
these population-level data accessible to biologists. We will use up to 28 years of data from the U.S. Health and
Retirement Study (HRS), a population representative sample of adults aged 50+ (N=18,000) who have high-
density genotypic data, and transcription and methylation data (n~4,000), and over 16 years of data from the
English Longitudinal Study of Ageing (ELSA) genetic sample (N=7,407). Available phenotypes include
biomarkers curated from blood, methylated DNA or telomeres, as well as indices of functional ability, including
physical status, disease conditions, cognitive functioning, frailty or mortality indicators, and environmental and
behavioral phenotypes. Aims of the GTASC are to: (1) Accelerate translational research on human aging by
interrogating findings derived from model systems in human population data; (2) Develop the resources and
tools that can be expediently invoked for customized translational analyses; and (3) Develop new research
directions using model systems, which entails designing and developing analytical plans for experimental and
mechanism-based studies based on findings from human data. Increased access to cross-translational
resources to validate model system findings in humans, generate additional hypotheses under natural human
conditions, and use empirically-driven approaches for experimental designs will lead to an accelerated pace for
gaining novel insights into processes in aging, and pave a faster route to intervention and treatment studies. The
innovative combination of population genomics, biological markers, bioinformatics, and expertise in phenotype
development to mark mortality, disease, and functionality is what gives this GTAS Core its uniqueness as a
resource.